Photoelectrocyclizations to Virulence Inhibiting Natural Products

The increasing prevalence of drug resistant bacteria has resulted in a dire need for new approaches
to antimicrobials. In particular, the discovery and development of small
molecules that are not as predisposed to selective pressure and, as a consequence, offer
fewer opportunities for the development of resistance, is a topic of current interest and one where
we believe we can help to make a difference. This proposal outlines our program is
concentrated on developing novel scaffolds aimed at disrupting bacterial communication and
virulence, especially in gram-positive bacteria. We propose to study two natural product
lead molecules over the course of four phases that combine the development of organic chemistry
methodology with total synthesis and SAR. Concurrent to these efforts will be studies whose goals
are to ascertain the ability of our synthetic compounds to control virulence. The choice of
inhibitors to begin our studies has taken into account the accessibility of the small molecule
targets using efficient and novel chemical synthesis methodology, the activity of the targets
against virulence targets, including sortase A, and the ability of the compounds to
inhibit biofilm formation and to disrupt preformed biofilms. Our lead structures are
discorhabdin Z, a pyrroloiminoquinone natural product that comes from the marine sponge, Sceptrella
sp. and taxodone, a diterpene natural product of the abietane family that comes from the roots of
the sage Salvia austriaca. Both of these agents will synthesized using a unique and
stereoselective bis-aryl alkene photochemical electrocyclization reaction sequence. We will
continue to develop and optimize the photoelectrocyclization reactions over the course of the
proposed efforts. In the third phase of the program we will generate analogs of
discorhabdin Z and taxodone aimed at enhancing their virulence activity while tempering,
for the discorhabdins, their cytotoxicity. The final phase of the work proposed here
will be carried out in collaboration with the University of Utah Medicinal Chemistry Core
Facility and will target the development of a panel of assays aimed at gathering information about
the antibiotic activity, anti-biofilm activity, sortase A activity, and toxicity of all of our
synthetic compounds.

Public health relevance
The proposed studies promise to better understand and develop novel therapies for the treatment of bacterial infections and are critical to the mission of the NIH and public health. We are specifically interested in developing novel and innovative therapies that are less susceptible to selective pressure and the development of bacterial resistance as a consequence of their ability to disrupt bacterial communication and virulence.